Cellular Programming in Persistent Versus Lytic Viral Infections

CELLULAR REPROGRAMMING IN PERSISTENT VS. LYTIC VIRAL INFECTIONS
PROJECT SUMMARY
The long-range goal of the proposed research is to define the cellular factors that mediate JC polyomavirus
(JCPyV) infection to better understand how virus-host cell interactions influence viral pathogenesis. JCPyV
infects up to 80% of the population and establishes a lifelong, asymptomatic persistent infection in the kidneys
of healthy individuals. However, in immunocompromised individuals JCPyV can spread to the central nervous
system (CNS) and cause a lytic infection in glial cells resulting in the fatal, demyelinating disease progressive
multifocal leukoencephalopathy (PML). Approximately 5% of individuals with HIV develop PML, a terminal AIDS-
defining illness, and individuals receiving immunomodulatory therapies for diseases including multiple sclerosis
are at heightened risk for PML development. The increasing number of individuals receiving immunomodulatory
therapies due to immune-mediated diseases has led to a rising number of PML cases in the past decade. Over
700 total cases of PML are due to a single drug class. PML can be fatal, especially when underlying
immunosuppression is left untreated, and there are currently no approved treatments for this devastating
disease. The lack of an animal model and limited cell culture models have largely restricted studies of JCPyV to
a single transformed cell culture model. Recently-published studies have revealed that primary cell culture
models are a better representation of disease pathogenesis in vivo, and thus we have developed innovative
primary cell culture models to define cellular factors that are required for JCPyV infection. Two integrated specific
aims are proposed in this research project to: 1) characterize cellular factors that mediate JCPyV entry and
infection in primary cell types, and 2) elucidate cell-type dependent differences in persistent and lytic JCPyV
infections. This research will enhance our understanding of how virus-host cell interactions influence disease
outcomes and will serve as a platform for the development of antiviral treatments. Through this work, cellular
factors required for JCPyV entry in primary cell types will be characterized through loss- and gain-of-function
approaches using cell-based assays. Transcriptome profiling through RNA sequencing analysis will be used to
determine how JCPyV infection alters gene expression in a cell-type dependent manner to identify pathways
relevant to JCPyV pathogenesis and fatal disease outcomes. This combinatorial approach utilizes newly
developed primary cell models of JCPyV infection and takes advantage of innovative high-throughput analysis
of viral and cellular protein expression and RNA sequencing approaches. This research will fill key gaps in our
knowledge of JCPyV biology and could elucidate novel antiviral targets or provide rationale for experimental use
of on-market therapies to prevent or treat the fatal disease PML. Findings obtained from this research will also
provide broader insights into the entry and signaling networks for other pathogenic viruses, like coronaviruses,
and improve our understanding of dysregulation of cellular signaling in other diseases such as cancer.